Understanding and Improving Therapies for the Muscular Dystrophies

Abstract

This Wellstone MDSRC is organized around the central theme of preserving skeletal muscle and cardiac
muscle function in the muscular dystrophies by delineating disease-­modifying targets and developing
therapeutic strategies. We have shown that inhibiting inflammation/fibrosis will improve skeletal muscle repair
and limit fibro-­fatty replacement of both skeletal muscle and cardiac muscle. We now are additionally focused
on the metabolic aspects of the muscular dystrophies, as well as the impact of calcium handling dysfunction in
both cardiac and skeletal muscles, and the development of therapeutics to address these problems. Project 1
(Drs. Sweeney and Hammers) will evaluate anti-­inflammatory and anti-­fibrotic drugs in the course of
delineating the short-­comings of AAV-­µdystrophin gene therapy, and developing therapies to improve its
effectiveness. Preliminary data suggests that the hearts of dystrophin-­deficient animals will not be rescued by
µdystrophin gene therapy unless additional means of addressing calcium dysfunction in the heart can be
developed. In Project 2, Drs. McNally and Spencer will examine the effects of intermittent steroid dosing on the
inflammatory infiltrate in muscle, determining how metabolic programming alters this process and how this is
reflected in blood biomarkers. Together, they will also investigate a novel agent directed at promoting CaMKII
activation. This project takes advantage of Dr. Spencer’s expertise in profiling immune cells in muscle and will
also use human materials collected from the Weekly Steroids in Muscular Dystrophy (WSiMD, NCT04054375 )
trial. In Project 3, Drs. Walter and Vandenborne will continue to develop non-­invasive biomarkers for following
disease progression as well as conduct human studies that complement the mouse studies of Projects 1 and
2. Our Physiological Assessment Core (Core C: Shared Scientific Resource Core), under the direction of Dr.
Barton, will support Projects 1 and 2, as well as continue as a national resource for evaluating therapeutic
interventions in mouse models of muscular dystrophy. This Center has a major training and educational
component (Core B: Training Core), under the direction of Drs. Andrew Judge (UF) and Rachelle Crosbie
(UCLA).

Public health relevance
Narrative The goal of this Wellstone Muscular Dystrophy Specialized Research Center is to identify emerging therapeutic targets and therapeutics, as well as to develop imaging tools to monitor the efficacy of therapies, that control inflammation, fibrosis, and disease progression in a number of muscular dystrophies. We also are focused on understanding the mechanisms and unwanted side effects of current therapies (e.g. corticosteroids) in order to improve upon their efficacy and use. With the dawn of gene therapy for Duchenne muscular dystrophy, we feel it is imperative to understand the deficiencies of the emerging treatments in order to improve upon them before the deficiencies become evident in patients.